GM/CA@APS Sector Development

This interagency transfer to the United States Department of Energy supports personnel, equipment, supplies and operation of beamlines 23-ID-B, 23-ID-D and 23-BM for macromolecular crystallography at the Advanced Photon Source at Argonne National Laboratory. Specifically, this transfer is to partially support the purchase of a new x-ray detector for the synchrotron beamline jointly supported by the National Institute of General Medical Sciences and the National Cancer Institute.